TRANSFER OF AMMONIA TO THE URINE IN AUTOSOMAL DOMINANT POLYCYSTIC KIDNEY DISEASE

To determine whether patients with ADPKD can transfer ammonia (NH3) normally to the urine. If not, this results in a subclinical renal acidosis, which under certain conditions may contribute to the predisposition of these patients to renal calculi, parenchymal calcifications, and interstitial renal disease.